Transmission Links and Clinical Spectrum of Exhaled Mycobacterium Tuberculosis

PROJECT ABSTRACT
Tuberculosis (TB) continues to pose a significant global public health challenge, with persistent
burden of over 10 million incident cases likely perpetuated by millions of undiagnosed/unreported
TB cases contributing to global transmission. We recently observed an unexpected rate of viable
Mycobacterium tuberculosis (Mtb) aerosolization among individuals in a high burden TB setting
who test negative for Mtb in their sputum. In response to RFA AI-24-049 Halting Tuberculosis
(TB) Transmission, this study aims to investigate the role of sputum-negative, Mtb breath-positive
individuals in transmission and characterize their underlying clinical spectrum.
We will use original breath sampling techniques combined with an Mtb viability assay, highly-
sensitive molecular methods, and longitudinal clinical phenotyping with high-resolution imaging
to address two specific aims. First, we will assess the association between Mtb breath shedding
and transmission. Specifically, we will assess the prevalence of sputum-negative individuals who
shed viable Mtb in their breath across high and low TB burden settings. We will then estimate
their prevalence in transmission clusters by genotypically linking single nucleotide polymorphisms
in exhaled Mtb strains to sequenced Mtb isolates of sputum-positive household members. To
estimate infectiousness, we will compare the IGRA positivity rates of child household contacts in
sputum-negative, Mtb breath-positive households to those in exclusively sputum-negative, Mtb
breath-negative households. Secondly, we aim to examine the extent to which sputum-negative
exhaled Mtb reflects underlying pathology, immune activation, and disease progression versus
regression over time. We will thus characterize the clinical spectrum of sputum-negative exhaled
Mtb through high-resolution CT imaging, immune response markers, and detailed longitudinal
evaluations over 12 months.
By integrating breath sampling, genotyping, and clinical evaluations, this study will provide critical
insights into a potential hidden reservoir of undiagnosed TB transmission. These findings would
directly guide comprehensive and early/preventive diagnostic strategies for the missing millions
on the undiagnosed TB spectrum, in turn reducing the global burden of TB disease and
transmission.

Public health relevance
PROJECT NARRATIVE This project investigates whether individuals who exhale tuberculosis (TB) bacteria in their breath, despite testing negative for TB on standard sputum tests, may still infect others. We will also study the underlying disease condition and clinical evolution of these individuals who exhale TB bacteria to understand if they have or will develop TB illness. This research aims to uncover hidden sources of TB transmission and support the development of more effective diagnostic and prevention strategies for TB.